Assessing Differential Dyadic Mechanisms of Women’s Sexual Functioning

Project Summary/Abstract
Female sexual function (FSF) refers to how desire, arousal, orgasm, pain, pleasure, and satisfaction are experienced by
women. Female sexual dysfunction (FSD) is categorized into three DSM-5 diagnoses: sexual interest/arousal disorder,
female orgasmic disorder, and genito-pelvic pain/penetration disorder. Differentiating problems with FSF from FSD, the
morbidity criteria for FSD suggest there must be distress, symptom duration of at least six months, and experience of
dysfunction in 75% or more of sexual experiences. Approximately 40.9% of premenopausal women, and between 40-50%
of women regardless of menopausal status, experience FSD, which impacts subjective experiences of sex, increases
feelings of distress (e.g., sadness, guilt, anxiety), and reduces their overall quality of life. Incidences of specific types of
FSD include decreased desire (26.4-28.42% of premenopausal women), genital arousal (15.4-22.6%), lubrication of the
vagina (16.3-20.6%), orgasm (20.9-25.7%), and increased sexual pain (14.4-20.8%). Black women are an understudied
demographic within FSF/FSD research, despite research suggesting they find sex more important than women of other
races. The Heteronormativity Theory of Low Sexual Desire (HTLSD) asserts socio-structural factors such as
heteronormativity, expressed via romantic relationship dynamics, impact FSF, but Black women face the added
intersection of racism. Intersectionality suggests racism compounds the negative impact of heteronormative socio-
structural oppression on Black women’s sexual functioning. Notably, Black women's cultural values (e.g., collectivism)
may moderate how relationship factors influence FSF/FSD due to socio-structural oppression, thus romantic relationship
dyads are one area ripe for assessment and future intervention development. Aligned with PAR-21-281 (NIMHD and
Office of Women’s Health priorities), innovation is needed to accurately capture the dyadic process of how Black
women’s partners’ report of relationship factors (e.g., romantic gender roles and other variables related to the HTLSD)
influence Black women’s FSF/FSD. Additionally, as White women have been the focus of most US-based FSF/FSD
studies, examining the differential relationship predictors of FSF/FSD among Black and White women is an important
step toward racially specific FSF/FSD interventions. The Assessing Differential Dyadic Mechanisms of Black and
White Women’s SEXual FUNctioning (ADD SEX FUN) project will employ an intersectional adaptation of HTLSD,
using a Black feminist, comparative mixed-method, dyadic examination of relationship factors associated with Black and
White women's sexual functioning through actor-partner interdependence modeling (APIM). ADD SEX FUN will also
employ dyadic qualitative interviews (dyadic framework analysis, relation mapping) and focus groups to glean the lived
experience of Black women and their partners related to FSF/FSD, eliciting the key moments in their relationships that
influenced FSF/FSD. ADD SEX FUN will conclude with a message test to determine which FSF/FSD messages distilled
from the first and second project aims are preferred among Black women’s romantic partners, based on partner
demographic and attitudinal profiles (latent profile analyses). The overall goal of the project is to identify modifiable
relationship dynamics that are acceptable for dyadic FSF/FSD intervention among Black women and their partners.

Public health relevance
Public Health Relevance Statement This project will study romantic relationship influences on female sexual dysfunction. It will also establish which messages about sexual functioning align most with distinct demographic and attitudinal profiles of women’s romantic partners, providing an evidence base upon which to develop or adapt dyadic sexual functioning interventions for women and their partners.